NEONATAL DRIED BLOOD SPOT METHYLATION AND CONCEPTION BY INFERTILITY TREATMENT IN THE UPSTATE KIDS STUDY

To perform an epigenome wide association study using newborn DBS from the Upstate KIDS Study for understanding how infertility treatment impacts DNA methylation patterns in offspring at birth.